UAW Hazardous Material Worker Health and Safety Training (U45)

Program Summary/Abstract
The International Union, UAW and its partners propose to address three problems. The first
is the potential for illness and injury directly or indirectly related to hazardous material
exposure. The second is occupational and environmental health disparities, particularly as they
affect the Hispanic/Latino population of Southeast Michigan. The third problem is the opioid
epidemic, an emerging environmental health issue.
To address the first problem, we will continue development of an ongoing program whose
paramount goal is to prevent illnesses and injuries by providing training on health and safety
topics that are directly or indirectly related to elimination and/or reduction of potential
exposure to hazardous materials. UAW members throughout the United States are exposed to a
wide variety of hazards. Manufacturing workers can face exposure to carcinogens, such as
welding fume and hexavalent chromium and emerging hazards, such as engineered
nanomaterials (ENM). Members employed in casinos are often heavily exposed to carcinogenic
tobacco smoke. In healthcare and academic labs, union members can be exposed to bloodborne
pathogens, sterilants, radioactive isotopes and/or emerging hazards, such as ENM. The UAW
has established a partnership with the University of Puerto Rico to provide training to the
union’s six thousand active members on the island who are still dealing with the aftermath of
Hurricane Maria.
The second problem is occupational and environmental health disparities in Southeast
Michigan, where the Hispanic/Latino population includes many who are disadvantaged by
environmental injustice, less formal education, limited English proficiency, and/or limited
access to training. The UAW is working with two partners who serve the Hispanic/Latino
communities in Southeast Michigan, Catholic Charities of Southeast Michigan – Hispanic
Outreach Services (CCSEM/HOS) and La Casa Guadalupana. Many in these populations are
exposed to pesticides when doing landscaping or agricultural work, silica and other dust when
working in construction and/or toxic cleaning solvents when working in housekeeping or
childcare. Some work outdoors, where they are exposed to temperature extremes, UV radiation
and/or air pollutants. They may work 6-7 days per week in jobs characterized by seasonal
instability, shifting hours, low pay and physically harmful or dangerous work conditions.
The third problem is the opioid crisis, which has affected many UAW members, especially in
manufacturing.
In the first year of the grant, the UAW and its partners together propose to train 2,661
participants in 163 programs for a total of 20,442 contact hours. The five-year totals would be
13,305 participants in 815 programs for a total of 102,210 contact hours. The consortium
proposes to address the potential for illness and injury directly or indirectly related to hazardous
material exposure by conducting training in health and safety. We will address occupational
and environmental health disparities by continuing and expanding collaborative partnerships
with community groups and other NIEHS-WTP grantees for the purpose of delivering health
and safety training to underserved populations. The opioid crisis will be addressed by
developing and delivering population-specific curricula that address treatment and prevention
of opioid addiction, including alternatives for pain management. In addition, we propose to
develop, pilot, evaluate, and scale a peer recovery support program that will help workers seek
services to address opioid addiction.
All of the above programs will be evaluated to provide feedback for continual improvement of
curricula and delivery methods. This will include monitoring trainee perceptions of quality,
appropriateness, and usefulness as well as assessing new curricula and training delivery
methods; evaluating the long-term impact of training on worker and organizational outcomes
using innovative and conventional quantitative and qualitative evaluation methods. Worker-
evaluators will be incorporated into evaluation when possible.

Public health relevance
Project Narrative The International Union, UAW and its partners propose to address three problems. The first is the potential for illness and injury directly or indirectly related to hazardous material exposure. The second is occupational and environmental health disparities (Strategic Plan Goal 4 for Promoting Translation), particularly as they affect the Hispanic/Latino population of Southeast Michigan. The third problem is the opioid epidemic, an emerging environmental health issue (Strategic Plan Goal 5 for Promoting Translation). We propose to conduct training in health and safety in order to address the potential for illness and injury directly or indirectly related to hazardous material exposure by conducting training in health and safety. We will address occupational and environmental health disparities by continuing and expanding collaborative partnerships with community groups and other NIEHS-WTP grantees for the purpose of delivering health and safety training to underserved populations. The opioid crisis will be addressed by developing and delivering population-specific curricula that address treatment and prevention of opioid addiction, including alternatives for pain management. In addition, we propose to develop, pilot, evaluate and scale a peer recovery support program that will help workers seek services to address opioid addiction. All of the above programs will be evaluated to provide feedback for continual improvement of curricula and delivery methods. This will include monitoring trainee perceptions of quality, appropriateness, and usefulness as well as assessing new curricula and training delivery methods; evaluating the long-term impact of training on worker and organizational outcomes using innovative and conventional quantitative and qualitative evaluation methods. Worker trainers will be involved in evaluations when possible. In doing all of the above, we further EPA’s mission to protect human health and the environment and Congress’s purpose in passing the Occupational Safety and Health Act of 1970 “to assure so far as possible every working man and woman in the nation safe and healthful working conditions…”